Mentoring patient-oriented research to improve cardiovascular health among people with HIV in sub-Saharan Africa

PROJECT SUMMARY
Overview. This K24 mid-career investigator award will support Dr. Mark Siedner to lead a mentoring program
in patient-oriented research on detection and prevention of cardiovascular disease among people with HIV in
sub-Saharan Africa.
Candidate. Dr. Siedner is a physician scientist who serves as principal investigator (PI) or co-PI of four NIH
R01-funded patient-oriented research (POR) projects on HIV and/or cardiovascular disease in sub-Saharan
Africa, leading to over 220 peer-reviewed publications. He has also proven himself to be a highly successful
mentor, with over two dozen past and current trainees, receipt of the Harvard Medical School Young Mentor
Award, and evidenced by his role as co-director of an NIH T32 program in HIV clinical research at MGH (T32
AI007433), site PI of a global D43 clinical research training program on multimorbidity in Uganda (D43
TW011632), and program mentor in the Fogarty Clinical Research Fellowship (D43 T010543).
Mentoring plan. This K24 award will allow Dr. Siedner to protect 25% of his time to be dedicated for training
junior investigators in the US and sub-Saharan Africa in POR related to cardiovascular disease prevention
among people with HIV. He will leverage an established pipeline of clinical research trainees identified through
his leadership role on training grants and formalize a global cardiovascular disease research training program
that focuses on career advancement and pairs US and African scientists with collaborative projects.
Research Plan. Dr. Siedner will use the support provided by this award to pursue mid-career training in
machine learning and clinical risk prediction. He will leverage the machine learning training and partnerships
with experts in data science to comprehensively assess and validate individual and combinations of diagnostic
screening modalities for cardiovascular disease among people with HIV in sub-Saharan Africa (Aims 1 and 2).
This will be made possible with data from an NHLBI-funded R01 that includes CT angiography and extensive
risk factor data in 600 individuals in Uganda. In a second project, he will use risk prediction techniques to
derive and validate cardiovascular disease risk prediction scores among people with HIV in South Africa (Aim
3). This will be made possible by a Wellcome Trust-funded, population-based, longitudinal cohort study of over
18,000 people in South Africa who completed cardiovascular disease screening and are followed until
hospitalization and death. The proposed work is directly in line with research priorities outlined in NIH NOT-
020-013 including prevention of HIV co-morbid conditions across the lifespan and research training of a
multidisciplinary workforce. Moreover, Dr. Siedner’s longstanding commitment to training junior scientists in
POR, and particularly his dedication to the advancement of careers of women and individuals under-
represented in science, make him an excellent candidate for this award.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is a leading cause of morbidity and mortality among people living with HIV (PWH) including in sub-Saharan Africa where approximately 70% of the global population of PWH reside. However, CVD screening and prevention remains extremely limited in practice in that region, due in part to lack of patient-oriented research (POR) on diagnostic modalities and locally-derived risk prediction criteria. Dr. Mark Siedner is a clinician scientist and emerging leader in research on CVD among PWH who has an extensive track record of scientific mentorship in patient-oriented clinical research. This award will provide him the protected time and support to 1) develop a POR mentoring program on CVD research focused on PWH in sub- Saharan Africa, 2) grow the careers of promising scientists in this area, and 3) identify optimal CVD screening algorithms and risk prediction scores for PWH in the region.